Pediatric Emergency Department-initiated Support program To Link Care (PEDS-TLC) for youth with substance use

PROJECT SUMMARY/ABSTRACT
The purpose of this K23 career development award is to prepare Dr. Renny to become an independent
physician-investigator focused on improving care for youth with substance use through emergency department
(ED)-based behavioral interventions and use of technology to facilitate interventions and linkages more broadly
throughout health systems. In her K23 research project, Dr. Renny will address the critical deficit of research
on evidence-based approaches to link youth who use substances with needed outpatient care after their ED
visit. She will develop and pilot test a pediatric emergency department-initiated program, the Pediatric
Emergency Department-initiated Support program To Link Care (PEDS-TLC) for youth with substance use.
PEDS-TLC will link youth who report monthly or more substance use on the Screening to Brief Intervention
(S2BI) screening tool (“higher risk for a SUD”) with outpatient care (adolescent medicine or addiction
treatment, depending on severity of use) to receive further treatment after their PED visit.
In Aim 1, Dr. Renny will adapt and integrate into the electronic health record (EHR) an evidence-based brief
negotiated interview (BNI) and change plan for youth at higher risk of a SUD to facilitate linkage to care.
Following the ADAPT-ITT framework, and with the assistance of a key stakeholder board and pilot testing by
youth, Dr. Renny will adapt the BNI and change plan to be age- and setting-specific, including a more detailed
action plan and motivational interviewing theory-based post-PED messaging (e.g., appointment reminders,
action plan reminders) as part of the PEDS-TLC program. Once all components of PEDS-TLC are finalized,
the action plan and interim messaging will be integrated into the EHR through the EPIC MyChart Care
Companion application to assist with transition to outpatient care. In Aim 2, Dr. Renny will conduct a pilot
randomized controlled trial (RCT) of the PEDS-TLC program versus standard care to examine feasibility,
acceptability, and short-term efficacy of linkage to care and also substance use reduction at 30- and 90-day
follow-up.
During the K23 award period, Dr. Renny will build on her experience and skills as a pediatric emergency
medicine physician, medical toxicologist, and healthcare researcher to gain new expertise in: (1) adapting
behavioral interventions for youth with substance use; (2) engaging stakeholders in research; (3) usability
testing of information technology (IT) interventions; and (4) designing, executing, and analyzing behavioral
intervention trials for youth. She will receive in-depth mentorship from a multi-disciplinary team of experts in
ED-based behavioral health interventions, adolescent substance use, stakeholder engagement, IT and digital
health, clinical trials, and statistical analysis. The products of this K23 project will provide Dr. Renny with a well-
designed, innovative program (PEDS-TLC) and critical preliminary data that informs the anticipated effect size
and sample size needed for a subsequent NIH R01 RCT of PEDS-TLC.

Public health relevance
PROJECT NARRATIVE Youth substance use increases the risk of substance use disorder (SUD) and poor health outcomes, yet few youth in the United States receive treatment for their substance use. Emergency departments (EDs) commonly care for youth at risk for SUDs, and therefore serve as an access point to provide evidence-based behavioral health interventions that can facilitate linkage to outpatient care, and consequently reduce substance use and its negative outcomes. This K23 project addresses a critical gap in the research of targeted interventions for youth at risk for a SUD by developing and testing the Pediatric Emergency Department-initiated Support program To Link Care (PEDS-TLC), an electronic health record (EHR)-integrated program to link youth from the ED to outpatient care.